Neurometabolic profile of tobacco smoking in HIV-infected Individuals

Project Summary
Tobacco smoking is a serious public health concern and is 2 to 3 times more prevalent among HIV-infected
individuals than the general population. Smoking reduces the efficacy of combination antiretroviral therapy and
substantially impacts the long-term survival of HIV-infected individuals. Several studies have suggested that
chronic tobacco (cigarette) smoking and HIV infection have harmful additive or synergistic effects on the brain,
leading to greater psychopathology, impulsivity and cognitive dysfunction. Little is known about the
neurochemical profile related to the combined effects of HIV infection and smoking. HERCULES is a novel J-
difference-edited magnetic resonance spectroscopy (MRS) technique that can measure up to seven low-
concentration brain metabolites (e.g., GABA) with relatively short scan times. However, HERCULES is sensitive
to subject motion, which affects both localization accuracy and spectral quality. Both HIV-infected subjects and
tobacco smokers have greater impulsivity that might lead to greater subject motion. Therefore, the aims of this
project are: 1) K99 phase: the candidate will be mentored in the development of the motion-corrected
HERCULES sequence, which will allow robust investigation of these neurometabolites; he will also assess the
reproducibility of HERCULES with and without motion correction in seronegative (SN) healthy controls; 2) K99
phase: to learn to conduct a pilot clinical study using the optimized motion-corrected HERCULES to evaluate the
neurometabolic profile of HIV-infected individuals or tobacco smokers, compared to SN healthy controls; 3) R00
phase: to measure a comprehensive neurochemical profile in four groups of individuals (SN/tobacco-,
HIV+/tobacco-, SN/tobacco+, HIV+/tobacco+), using the motion-corrected HERCULES sequence. Based on the
proposed clinical training and didactic courses, the candidate will work with experienced globally recognized
experts in the fields of MRS and clinical HIV research to achieve five training goals: (1) develop expertise in
research design and clinical assessments of HIV-infected individuals and tobacco smokers; (2) conduct a pilot
study to evaluate the independent effects of HIV and tobacco smoking on neurometabolite levels; (3) learn to
apply an advanced MRS technique to clinical research, especially in HIV+ individuals and tobacco smokers; and
(4) learn to apply advanced statistical methods to analyze complex clinical data from patient populations. The
long-term career objective of the candidate is to become an independent scientist with a complete repertoire of
skills in MRS methodologies and their clinical applications. The motion-corrected HERCULES can be applied to
study metabolic processes in other diseases as well, adding scope and impact to this research proposal, which
is also responsive to NIDA’s mission of “strategically supporting and conducting basic and clinical research on
drug use (including nicotine), its consequences, and the underlying neurobiological mechanisms involved.”

Public health relevance
Project Narrative The prevalence of cigarette smoking among HIV-infected individuals is 2 to 3 times greater than in the general population, and smoking has deleterious effects on the long-term survival of these individuals. Chronic cigarette smoking and HIV infection may lead to additive or synergistic effects on the brain and cognitive deficits. The proposed research will develop a new magnetic resonance spectroscopy scan that allows robust measurements of brain chemicals to investigate the independent and combined impact of HIV infection and tobacco smoking on the human brain and enhance our understanding of the biochemical processes that may contribute to cognitive decline in HIV-infected smokers.